Covalent PD1 Antagonists: Discovery of Protein-Protein Interaction (PPI) Inhibitors in Cancer Immunotherapy

7. Project summary. Protein–protein interactions (PPIs) play a pivotal role in regulating a plethora of biological
processes and their misregulations have been associated with a variety of diseases. Modern proteomic tools
enabled over 600,000 PPIs to be identified as potential targets, which can be validated at an incredible pace by
programmable gene-editing point-mutations in mammalian cells. Given these technological advances, the
modulation of intra- and extracellular PPIs has emerged as one of the most exciting strategies towards next-
generation therapeutics. Yet, the development of PPIs inhibitors is lagging far behind the other successful drug
modalities (antibodies and small molecules) due to the challenges associated with the large, shallow, often
dynamic, and water-exposed binding interfaces. Therefore, we propose to study novel PPI inhibitors modalities
via -hairpin peptides featuring large binding-surface areas inspired by the long non-canonical loops forming
antibody paratopes. Our goals are to preserve the high-affinity and binding specificity of antibodies by mimicking
the binding-competent conformation of CDR-H3 loops sequence to disrupt PPIs. This research proposes to
exploit -hairpin scaffolds synthesized in our lab to recreate antibody loops of conceptually any sequence, length,
and conformational plasticity (aim 1). As a proof-of-concept (PoC), a structure-guided approach from X-ray
crystal structures of protein–antibody drug complexes will be followed to rationally design PPI inhibitors of the
programmed cell death 1 (PD1) immunoreceptor and its ligand 1 (PDL1). Indeed, the PD1/PDL1 interaction
inhibits T-cell effector function in a process known as tumor immune evasion, and its blockade has proven to be
an effective strategy to restore T-cell proliferation in different cancer-types. To validate our PoC, covalent
inhibitors will be designed by crafting electrophilic warheads at specific loop positions of the most potent -hairpin
binders (aim 2). Overall, our strategy combines the synthesis of -hairpins bearing strained loops (N > 12-
residues) that closely mimic the large binding contacts of antibodies CDR-H3 loops to create high-affinity
inhibitors with the positioning of electrophilic warheads for covalent binding at the PPI interface. A series of novel
electrophilic warheads will be evaluated to target a distinctive lysine residue (K131) located at the center of PD1
binding epitope. A structure–activity optimization will also be achieved by alanine-scanning to validate the most
promising cell-penetrating hairpin peptides in living cells (PBMCs). This strategy of CDR-H3 mimicry into
covalent -hairpins could potentially be a game-changer by revisiting peptide drugs that are not able to bind
tightly and selectively to extra- and/or intracellular proteins and often abandoned during preclinical studies due
to a lack of in vivo activity. As a result, a large number of protein targets associated with various diseases could
become druggable and offer new possibilities in the space of PPI inhibitors for drug discovery.

Public health relevance
8. Project Narrative. PD1 is an immune checkpoint protein that acts as a brake on signaling proteins that trigger an innate immune response to cancer and ultimately allow tumor evasion. While FDA-approved monoclonal antibodies provided compelling clinical results in various cancer types, the development of small-molecule drugs inhibiting such protein–protein interaction (PPI) is lagging far behind. To bridge this gap, and reignite antitumor immunity to inhibit the growth of these immunosuppressive tumors, we are developing β-hairpin drugs that closely mimic and miniaturize antibody loops while covalently binding to PD1.